Activity Space Adversity and Racial Disparities in Adolescent Health

PROJECT SUMMARY
Prior research has documented substantial differences in levels of physiological stress among Black- and White-
identifying individuals during adolescence, a period of particular importance from a developmental perspective,
which may shape disparities in chronic disease in adulthood. The proposed project seeks to explore the role of
exposure to multiple dimensions of activity-space adversity (ASA) – including area-level violence, elevated
policing, and racial exclusivity – in contributing to everyday (real-time) perceptions of both physical and
psychological unsafety and their contribution to explaining racial physiological stress disparities during
adolescence (Aim 1). We will also consider the impact of ASA exposures, unsafety perceptions, and
physiological stress as predictors of substance use and mental health outcomes (Aim 2). We will explore the
moderating influence of other-perceived race – or the degree to which an individual believes others perceive
their race to be Black in public interactions – on ASA exposure and unsafety effects on physiological stress and
health outcomes. The project will collect aim-relevant data on a racially diverse cohort of adolescents residing in
the Columbus, OH metropolitan area employing an innovative two-stage design: The first phase will produce rich
cross-sectional data (N=700) including standard survey items for youth and their caregivers; estimates of youth
ASA exposures from self-reported routine activity locations combined with extensive contextual ratings and
administrative data, physiological stress markers (cortisol and inflammatory), and health outcomes. The second
phase will involve a supplemental intensive longitudinal data collection period taking place over a six-month
period for a subsample of Phase 1 youth (N=300) selected using a novel exposure-based sampling strategy.
Data collected during this supplemental phase will include an unprecedented combination of continuous high-
resolution GPS tracking; ecological momentary assessments of perceived psychological and physical safety;
continuously-sensed heart rate variability; and hair cortisol concentration and C-reactive protein measured at
three additional time points. In addition to analyses of the novel data sources produced by the project, by drawing
on data from the Adolescent Health and Development in Context Study (2014-2016) previously conducted by
our study team, we will also examine recent historical changes in ASA exposures, racial disparities in safety and
physiological stress, and their health consequences.

Public health relevance
Project Narrative The objectives of this study are to determine the impact of exposure to adverse activity spaces characterized by high area-levels of violence, policing activity, and racial exclusivity on everyday perceptions of safety, physiological stress, mental health and substance use. We will also consider whether the impact of adverse exposures on safety, stress, and health is greater for youth who believe others perceive their race to be Black in public interactions. Finally, we will explore whether changes in the extent and impact of adolescent adverse activity space exposures have occurred since the period prior to the COVID-19 pandemic.